Boston University's Alzheimer's Disease Center

Please refer to Research Strategy for all changes and additions to original Aims.

Public health relevance
Please refer to Research Strategy for all changes and additions to original Aims.